Hippocampal Mechanisms of Stress-Induced Generalization of Negative Memories

PROJECT SUMMARY
!
Major Depressive Disorder (MDD) and Generalized Anxiety Disorder (GAD) are debilitating and widespread
disorders for which current treatments are unfortunately insufficient, particularly for associated cognitive
symptoms. These cognitive symptoms, which include impairments of memory, executive function, and cognition,
precede and predict the development of affective symptoms, thus they likely contribute to the development of
associated affective symptoms. Given this, treating or preventing cognitive symptoms may prevent or lessen
other symptoms of MDD and GAD. Unfortunately, our understanding of the neurobiological mechanisms
underlying these cognitive symptoms is limited. A reliable and common cognitive deficit seen in MDD and GAD
is overgeneralization of negative memories, defined as making sweeping conclusions based on a single past
negative experience (e.g.: if I fail at this job interview, I will perform poorly on all my future interviews as well).
Stress is known to promote generalization of negative memories; however, how this process occurs is not known.
Thus, a better understanding of how stress alters neural circuits to promote generalization of negative memories
is needed to elucidate the neural mechanisms underlying disease-relevant behaviors. On this basis, and
consistent with NIMH's research domain criteria (RDoC) initiative, I propose to study the mechanisms of stress-
induced generalization of negative memories (SIGNM) as an endophenotype of MDD and GAD.
To this end, I developed an animal model for SIGNM by combining contextual fear conditioning with social
defeat stress. I will use this model to elucidate cellular and molecular mechanisms of SIGNM. A promising
candidate region is the dorsal hippocampus (DH) given (1) its role in associative learning, social memory, and
episodic memory, (2) the fact that abnormal DH function has been implicated in generalization of memories in
rodents and humans, and (3) that my pilot data shows that glutamatergic DH neurons mediate SIGNM. The DH
is thought to encode contextual memories through organized ensembles of active neurons, commonly termed
engram cells. Increased overlap of engram cells encoding different contextual memories is theorized to underlie
increased generalizability between those contextual memories. Given this, increased overlap of neurons
encoding negative event-associated and neutral contexts may provide a potential mechanism for SIGNM. I will
explore this hypothesis in aim 1. To then explore circuit mechanisms of SIGNM, I will explore the contribution of
DH glutamatergic outputs to RSC in SIGNM (Aim 2.) These projections are of promise as DH glutamatergic
outputs to the RSC have been shown to mediate contextual fear memory processing. Next, as my pilot data
shows that muscarinic acetylcholine receptors in the DH are necessary for SIGNM, I will then explore the role of
cholinergic medial septum projections to the DH, the predominant source of DH acetylcholine, in SIGNM (Aim
3.) Upon completion of these experiments, I expect to have identified novel cellular and circuit mechanisms of
SIGNM that can serve as RDoC for GAD and MDD, as well as novel therapeutic targets for these disorders.

Public health relevance
PROJECT NARRATIVE Cognitive deficits, including overgeneralization of negative memories, precede and persist with depressive and anxiety disorders, and often contribute to associated affective symptoms. To better understand overgeneralization of negative memories, I propose to identify, using animal models, the mechanisms underlying stress-induced generalization of negative memories. These mechanisms will inform the development of novel and more effective therapies for affective disorders. !